Elucidating the 3-D epigenetic determinants of activity-dependent gene expression in mammalian neurons

Abstract
Post-­mitotic neurons in the mammalian brain form synapses that dynamically remodel throughout an
individual’s lifetime to encode short-­ and long-­term memories. Synaptic plasticity involves spatiotemporal fine-­
tuning of gene expression levels in response to environmental stimuli, including rapid transcription of
immediate early genes on the time scale of minutes and longer-­term global chromatin remodeling. The cis-­
acting genetic and epigenetic elements that govern activity-­dependent expression are of outstanding interest
toward understanding how experiences sculpt the brain. Here, we submit a proposal entitled ‘Elucidating the 3-­
D epigenetic determinants of activity-­dependent gene expression in mammalian neurons’. We have assembled
an interdisciplinary team with critical expertise in genome folding, epigenetics, chromatin engineering,
neurobiology, synaptogenesis, electrophysiology, and computational biology. We aim to elucidate the causal
link among long-­range looping interactions, epigenetic modifications on the linear genome, expression of their
spatial target genes, and the activity of mammalian neurons. We hypothesize that immediate early genes will
functionally engage in singular short-­range loops to rapidly activate expression on the time scale of seconds to
minutes in response to the environmental stimulus of neuronal activation. By contrast, we posit that secondary
response genes will spatially connect via architectural proteins into complex, long-­range, pre-­existing
topological configurations to poise the genome for a second wave of expression on the order of hours to days
in response to neuronal firing. To test our hypotheses, we will create high-­resolution genome folding maps
using the Hi-­C during a time course of activation in mouse hippocampal neurons. We will identify activity-­
dependent enhancers and gene expression genome-­wide and determine their temporal profile with respect
pre-­formed and activity-­dependent loops. We will formulate mathematical models to predict activity-­dependent
expression of immediate early genes and secondary response genes from the timing of enhancer activation
and looping contacts. By integrating single nucleotide variants linked to autism, schizophrenia, bipolar disorder,
addiction, and attention-­deficit/hyperactivity disorder with our models, we will predict the specific target genes
and potential pathways involved in neurological disease. Finally, we will dissect the functional role for loops
and enhancer activity in regulating the activity-­dependent transcription of Bdnf and c-­fos using CRISPR
genome editing of architectural protein binding motifs and CRISPRi inhibition of specific enhancers. Our work
will uncover the genome’s long-­range interaction landscape in mammalian neurons and reveal the causal link
between the 3-­D Epigenome and the kinetics of transcriptional response to environmentally stimulated
neuronal activation.

Public health relevance
Public Health Relevance/Narrative Brains have evolved to process and store information from the outside world and do so through synaptic connections among interconnected networks of neurons. Our work will illuminate higher-order genome folding as an unexplored dimension of the long-range epigenetic control governing neuronal activation in the mammalian brain. Synaptic defects underlie many neurological disorders, therefore understanding the molecular mechanisms governing activity-dependent expression is of tremendous importance toward our knowledge of how neural circuits are disrupted in brain disease.